Telehealth Post-Pandemic: A Roadmap for the Coming Decade

Project Summary
The COVID-19 pandemic necessitated the rapid implementation of telehealth, leading to limited reflection on
how to sustain quality care and what permanent policies are needed for continuing these services. Therefore,
the objective of this proposed conference is to convene a Think Tank to develop and disseminate best practices
for providing high-quality telehealth care and promoting policy changes that support equitable access to
quality, safe, and efficient healthcare for all Americans. This Think Tank will assemble a multi-disciplinary
group of decision leaders from health systems, physician groups, researchers, patient advocates, technology
groups, insurers, and policymakers from Michigan. Michigan is an ideal setting for this conference because of
its racial, political, cultural, economic, and geographic diversity. Thus, the guidance developed through this
Think Tank will be able to be translated nationally. The rationale is that this conference provides a timely
opportunity for these groups to reflect on the quick shift to providing telehealth during the pandemic and
chart a course for best practices and next steps to ensure its sustainability. There are two specific aims for this
Think Tank: 1) Develop practice, policy, and research priorities to guide evidence-based guidelines for
providing telehealth services, and 2) Actively distribute these priorities to a national audience. For the first
aim, Think Tank will cultivate connections among healthcare providers, health systems, government, industry,
and researchers engaged in telehealth. Through a pre-conference literature review, key topics will be
developed, and workgroups will be formed to delve into the issues and document gaps and evidence-based
practices. For the second aim, the team will leverage partnerships with Connect America, Blue Cross Blue
Shield, and the Journal of Telemedicine and Telecare to disseminate Think Tank findings and
recommendations to a national audience. The team will also disseminate findings at national conferences,
through social media, and on its website to improve the use of telehealth, telehealth access, and the equitable
coordination of care. The conference deliverables will include a literature review, a website including blogs
and podcasts, at least six publications to be published in Telemedicine and e-Health, policy briefs, an updated
telehealth curriculum, and presentations at national meetings. This contribution is significant because the work
done at this Think Tank conference will directly inform policymakers’ and practice leaders’ decisions for
improving telehealth solutions to provide better access and healthcare to all patients. This will have tangible
impacts on and guidance for the sustained implementation of telehealth nationally.

Public health relevance
Project Narrative This project addresses the urgent need for sustainable, high-quality telehealth care following the rapid implementation of these services during the COVID-19 pandemic. By convening a multi-disciplinary Think Tank and disseminating best practices and policy recommendations, we aim to promote equitable access to safe and efficient healthcare for all individuals. Our approach aligns with AHRQ's mission to improve the quality, safety, efficiency, and effectiveness of healthcare for all Americans.